Treatment of chronic low back pain with transcutaneous auricular vagus nerve stimulation

Summary The application is a response to the National Institute on Drug Abuse Summer Research Internship Program, which supports undergraduate students with a focus on increasing underrepresented populations in drug abuse and addiction research. Specifically, as a supplementary award of an ongoing NIDA funded project entitled “Treatment of chronic low back pain with transcutaneous auricular vagus nerve stimulation” (R34DA046635), we will provide eight weeks of virtual training to the NIDA selected intern undergraduate student. The internship may include basic knowledge of clinical trials, chronic low back pain and brain imaging, chronic low back pain patient recruitment and screening, data collection, data analysis, participation in lab meetings, and literature reading. We hope that after training the student will solidify his interest in clinical research, particularly in chronic pain and drug abuse research.

Public health relevance
Narrative The aim of this supplemental application is to provide an eight-week virtual training to the NIDA selected intern undergraduate student from an underrepresented population. The training will provide the student with basic knowledge in clinical studies and aim to solidify his interest in clinical research.